A novel strategy for heart failure therapeutics

Abstract
Heart failure is a complex and heterogeneous clinical syndrome with significant morbidity and mortality
worldwide. Regardless of the heart failure etiology, cardiomyocytes initially develop adaptive morphological
hypertrophy that tends to reduce wall stress and prevent cardiac dysfunction, followed by transition to
maladaptive decompensation that ultimately leads to heart failure. Understanding the transcriptome
reconfiguration during transition can aid in preventing pathologic hypertrophy, the key driver of heart failure.
Recent advances in next-generation sequencing have dramatically expanded the scope of cardiac transcriptome
to non-coding RNAs, including microRNAs (miRNAs). Our preliminary studies discovered a novel miRNA (miR-
128) that is aberrantly upregulated in mouse and human failing hearts. The contributory role of miR-128 toward
heart failure was documented in a pilot study showing that cardiomyocyte-specific miR-128 overexpression in
mice causes eccentric cardiomyocyte hypertrophy with deteriorating cardiac functions. Mechanistically, we found
that the increased miR-128 in failing cardiomyocytes is due to epigenetic changes with hypomethylation of the
enhancer sequence in miR-128, leading to elevated recruitment of upstream transcription factor-1 (USF1) to
enhance miR-128 transcription. Additional mechanistic studies with affinity RNA pull-down followed by mass
spectrometry analysis revealed miR-128 interaction with the nucleocytoplasmic shuttling protein HNRNPA1.
Moreover, this protein is translocated into the mitochondria during cardiomyocyte failure, thereby also increasing
import of miR-128 into the mitochondria. In the mitochondria, miR-128 interacts with the heavy-strand promoter
(HSP) of mitochondria DNA (mtDNA) to suppress mitochondria DNA transcription thus leading to mitochondria
dysfunction and cardiomyocyte death. Based on these initial findings, we hypothesize that miR-128 inhibition
can reduce or prevent cardiac pathological hypertrophy in response to stress by directly reversing or ameliorating
mitochondria abnormality associated with cardiomyocyte failure. Specifically, we propose that applications of
epigenetic editing system containing sgRNA (targeting to USF1 motif in miR-128 enhancer) and scFv-GCN4-
DNMT3a (methylation of miR-128 enhancer) to silence miR-128 before or during early stages of cardiac
remodeling are effective strategies to alleviate stress-induced cardiac damage and reduce the mortality and
morbidity of heart failure. Three Specific Aims are proposed to test this hypothesis: Aim 1 will identify the
mechanism by which miR-128 contributes to cardiac pathological hypertrophy in mouse and human cellular
models, and evaluate the effects of miR-128 on pathological hypertrophy during cardiac remodeling. Aim 2 will
elucidate the mechanism underlying the impaired mitochondria homeostasis induced by miR-128 and the
trafficking mechanism of miRNA into the mitochondria. Aim 3 will interrogate the epigenetic mechanism of
aberrant miR-128 expression in heart failure, and test the hypothesis that epigenetic silencing of miR-128
enhancer is a viable therapeutic approach to prevent pathological hypertrophy during cardiac remodeling.

Public health relevance
Narrative This project discovers a novel mitochondria-enriched miRNA, miR-128, is important to synchronize cellular and mitochondrial biological process during cardiac remodeling. This miRNA will be an important target to direct correct or circumvent mitochondria abnormality in dysfunctional cardiomyocytes that accompanies heart failure. This proposal incorporates epigenomic information to investigate underlying mechanism involved in aberrant miRNA activation during heart failure and provides proof of principle that enable precise engineering of transcription regulation in cardiovascular medicine.